Administrative Core

Project Summary/Abstract
Administrative Core
The Administration Core will oversee all aspects of the Center and coordinate its activities. This includes a plan
for information transfer between projects as well as information dissemination to the scientific community and to
the public. Core A will be responsible for assuring that milestones are met and in consultation with NIH, will
appoint, and interact, with the External Advisory Board. The training and outreach programs will be administered
through Core A. Finally, Core A will oversee standard administrative tasks such as the budget and resource
allocations and maintain the Center web site. Dr. Haber will be responsible for the overall direction of the Center.
Dr. Rasmussen will coordinate the clinical aspects of the Center. Dr. Greenberg will lead the outreach program.
Dr. Quirk will lead the training program. A steering committee chaired by Dr. Haber will include the PIs and Co-
PIs of all Projects and Cores. This committee will meet monthly and be responsible for meeting scientific
timelines and milestones in a timely manner; interactions with the External Advisory Board, and oversee training,
outreach, resource allocation and reallocation, the web site, and resource and data sharing components of the
Center.